Birc5 as a regulator of NK cell development and immune function

ABSTRACT
Natural Killer (NK) cells are cytotoxic lymphocytes that mediate immune defense against viral pathogens and
tumors. In clincial settings, NK cells are being targeted in adoptive cell transfer (ACT) and hematopoietic stem
cell transplantation (HSCT) regimens, and immunotherapeutic approaches, to treat cancer and cancer-related
infections. Effective NK cell immunity is predicated on the sustained presence of a pool of functional NK cells in
the periphery. At steady state, the NK cell niche is maintained by the continual development of new NK cells
from progenitor populations in the bone marrow and by the homeostatic expansion of mature NK cells in the
periphery. In addition, certain inflammatory signals may transiently expand effector NK cells needed for
protection during infection or malignancy. Understanding the molecular pathways that control these processes
will critically impact the development of novel and more effective NK cell-based therapies in the clinic.
Our preliminary studies have highlighted a critical role for the Inhibitor of Apoptosis Protein (IAP), Birc5,
in NK cell hematopoiesis and function. Prior studies in stem cells and cancer cells have shown that Birc5
contributes to a broad range of cellular functions, including mitosis, survival, and cellular metabolism, acting
through its highly compartmentalized activities in the nucleus, cytoplasm, and mitochondria, respectively. A
role for Birc5 in NK cell biology has not been described. New data in our lab indicate that Birc5 is highly and
transiently upregulated in NK cells undergoing expansion in the context of development in the bone marrow, or
viral infection in the periphery. Further, our preliminary studies indicate that Birc5-deficiency severely impairs
mouse NK cell development and maturation. The specific cellular functions of Birc5 in NK cells, as well as its
roles in homeostatic- and infection-related NK cell expansion remain to be defined. Thus, we will conduct
studies that test the central hypothesis that Birc5 acts downstream of key cytokine and metabolic growth
signals to orchestrate NK cell expansion during development and peripheral immunity. These studies will utilize
novel transgenic mice, in which the Birc5 gene can be deleted in NK cells in a cell-specific or conditional
manner, to investigate the contributions of Birc5 to NK cell proliferation, survival, and metabolic function in
settings of development, homeostatic expansion, and anti-viral immune responses in vivo. Further, we will
combine sophisticated molecular and genetic techniques to define the environmental cues and intracellular
signaling networks that modulate Birc5 function in NK cells. And finally, we will use an innovative mouse
xenograft model to study Birc5 function in human NK cells in vivo. Ultimately, our studies have the potential to
inform ongoing and future NK cell-based immunotherapies, including adoptive cell transfer (ACT) and
hematopoietic stem cell transfer (HSCT) regimens that harness the anti-tumor properties of NK cells to treat
cancer.
!

Public health relevance
NARRATIVE Protective immunity relies on the sustained presence of functional immune cells, which requires the continual development of new immune cells in the bone marrow and the proliferation of mature cells in the tissues. Here we investigate the extracellular and intracellular signals that support the development and function of Natural Killer cells, which are critical for defense against viruses and tumors. !